Electronics Shop

ELECTRONICS CORE: Project Summary
The onsite Electronics Core service module has proven critical to the research productivity of
the NEI Core Investigators, and it continues to evolve to tackle the next generation of NEI
Investigatory needs in this area. Specifically, it has evolved from a primary focus on analog
electronic circuits, to a hardware/software design and integration hub. Broadly, the Electronics
Core designs, builds, and repairs advanced electronic hardware systems, which cannot be readily
obtained as off-the-shelf commercial sources. This allows our researchers to continually develop
state-of-the-art electronic devices and interfaces such as our recent advances in wireless
electrophysiology recording. Often these devices require high-end and user-friendly software
packages to control and/or integrate with either custom hardware or new applications for
purchased hardware. Our Electronics Core engineer is an expert in both hardware and software,
and provides engineering consultation throughout the development of projects and direct training
for personnel in regard to the functionality of new and modified electronic systems. The
Electronics Core, in collaboration with the Administrative Core personnel, disseminates novel
apparatus designs and other work products to the local research community to help the research
personnel access, re-use, and modify existing design files, and make contacts with expert peers
across the research community.